THE QUALITY OF LIFE &COGNITIVE ABILITIES IN PTS WITH CF

This NIH funded research is in conjunction with the Univ. of WI - Madison. The purpose of this study is to determine risk factors for the acquisition/colonization of the respiratory tract of children with CF. The hypothesis to be tested is that exposure during clinic visits of young children with CF to older patients who are colonized with Pseudomonas significantly increases the risk of acquisition of this organism in early childhood.